PGpR2 Year 3 Supplement for the Scientific Data Research Center (SDRC) of the GpCRC 4

Project Summary/Abstract
This proposal from Johns Hopkins University is to continue as the Scientific Data Research Center (SDRC)
to the Gastroparesis Clinical Research Consortium (GpCRC), sponsored by the National Institutes of Health
since 2006, to support the pediatric clinical centers as they continue to collect data and biospecimens for
participants ages 8-24 with symptoms of gastroparesis to create a Pediatric Gastroparesis Registry 2. The
SDRC original aims for the expansion of the Pediatric consortium were: 1) To develop and conduct a new
pediatric gastroparesis and functional dyspepsia registry of patients with symptoms of gastroparesis; and 2) To
coordinate and implement use of a single IRB (sIRB) to oversee all participating pediatric centers. Additional
aims are: 3) To conduct analyses for abstracts and publications; and 4) Support ancillary studies using banked
biospecimens to further the mechanistic research in children/young adults with Gp symptoms.
The SDRC will continue in the third year to provide leadership, expertise in biostatistical analysis, study
design, data system design and management, multicenter coordination, quality assurance, project support,
communication and organization, and will be responsible for supporting all future protocol development or
modifications, including providing sample size calculations, statistical advice, forms development, data analysis
and manuscript preparation. The SDRC will support development, implementation, maintenance, and data
monitoring of the real-time database of clinical information for the PGpR2 study, prepare de-identified
databases to submit to the NIDDK Central Repository for public-use and maintain a digital repository of
procedure output and specimen assay or genomic data. The SDRC will prepare all performance and data
monitoring reports for committees including the Steering and Executive Committees, Data and Safety
Monitoring Board (DSMB), and ad hoc reports that may arise. The SDRC will prepare protocols or future
protocol changes for submission to the SC, NIDDK program office, and DSMB, along with regulatory
documents and reports in support of any Investigational New Drug (IND) or Investigational Device Exemption
(IDE) applications on behalf of the NIDDK. Partnerships between GpCRC investigators and expert scientists to
use biospecimens and/or clinical meta-data to advance the understanding of the determinants of the
pathogenesis and progression of gastroparesis in the pediatric and young adult population will be supported by
the SDRC. The SDRC will collaborate with the clinical centers to coordinate procedures for preparation,
coding, and shipping of clinical center biospecimens to the NIDDK Central Repository and work with the
Repository to manage the receipt and inventory of biospecimens and de-identified Public-Use data for storage
in the NIDDK Central Repository and fulfilling investigator specimen and data requests. The SDRC will
manage the development, approval, and amendments of GpCRC policy statements, SOPs, ancillary studies,
presentations, and publications related to the Pediatric Gastroparesis Registry study.

Public health relevance
Project Narrative Gastroparesis is a disorder of gastric function characterized by delay in gastric emptying and frequently associated with chronic nausea and vomiting, early satiety, and abdominal pain, and can have a devastating impact on quality of life. The Pediatric Gastroparesis Registry 2 aims to expand on the first registry of pediatric patients with symptoms of gastroparesis for the enhanced study of symptoms, gastric motility abnormalities, patient characteristics, and degree of morbidity. This cohort will be followed to further define the natural history and clinical course of pediatric, adolescent, and young adult patients with symptoms of gastroparesis, and will provide a source for recruitment for other studies, including therapeutic clinical trials, pathophysiological, molecular, histopathologic, or other ancillary studies.